Multidisciplinary training in Alzheimer and related dementias

ABSTRACT/SUMMARY:
The Washington University T32 training grant “Multidisciplinary Training in Alzheimer and
Related Dementias” is designed to train the next generation of researchers in Alzheimer
disease and related dementias (ADRD). The training program will be led jointly by the
Knight Alzheimer Disease Research Center (ADRC) and the Hope Center for Neurological
Disorders at Washington University. The Knight ADRC and the Hope Center support a
highly collaborative environment that exemplifies multi-disciplinary team-based research.
Twenty-nine faculty from 11 Departments at Washington University will mentor trainees in
dementia research. The faculty include basic scientists, translational neuroscientists and
clinical investigators. Washington University has outstanding resources, including state of
the art facilities for translational research, biostatistics and informatics, and an excellent
track record in developing new therapies. The predoctoral students will be drawn from 9
different doctoral programs, including those affiliated with specific departments (Biomedical
Engineering, Psychological and Brain Sciences, and Social Work) as well as from programs
in the Division of Biology and Biomedical Sciences, including Biochemistry, Computational
and Systems Biology, Developmental, Regenerative and Stem Cell Biology, Human and
Statistical Genetics, Molecular Genetics, and Genomics and Neurosciences. Postdoctoral
trainees will be drawn from Chemistry and Developmental Biology, the school of
Engineering, clinical departments (Neurology, Medicine, Pathology, Psychiatry and
Radiology), Biostatistics, Psychological and Brain Sciences and the School of Social Work.
The training program will support 2 predoctoral trainees and 2 postdoctoral trainees; each
year the program will support 4 medical students for short-term summer training. Two of the
medical students will be from Washington University School of Medicine and two will be
recruited from Meharry Medical College School of Medicine. All trainees will be exposed to
patients affected by dementia and their families and will be trained in responsible conduct of
research. Predoctoral and postdoctoral trainees will have additional training in
bioinformatics and will be encouraged to utilize existing data from large cohorts in their
research projects. The program aims to develop a pipeline of diverse and rigorously trained
ADRD researchers.

Public health relevance
The Washington University T32 training grant “Multidisciplinary Training in Alzheimer and Related Dementias” is designed to prepare the next generation of researchers in Alzheimer disease and related dementias. The program emphasizes the collaborative, multi- disciplinary research that will be needed to find treatments for Alzheimer disease and other dementias.